HUMAN RESEARCH PARTICIPANT PROTECTIONS SUBJECT MATTER EXPERT SERVICES FOR NCI, DIVISION OF CANCER PREVENTION

The National Cancer Institute (NCI), Division of Cancer Prevention (DCP) requires advisory and assistive service across the Division’s clinical trial enterprise, to obtain specialized knowledge regarding ethical, legal and social issues relevant to DCP’s research portfolio; enhance DCP’s understanding of complex regulatory issues as it relates to the CPC CIRB; and to support the operation of DCP’s clinical trial program through skillful management of complex ethical and regulatory issues.